MULTICENTER-BLIND TRIAL TO EVALUATE RETROVIR AND ZOVIRAX

To evaluate the safety and efficacy of oral Retrovir therapy administered alone and oral Retrovir and Zovirax therapy administered concurrently in the treatment of early, symptomatic HIV infection.